Transcranial Direct Current stimulation for post-stroke gait rehab

Current rehabilitation methods fail to restore normal gait for many stroke survivors leading to dependence on
others, recurrent falls, limitations in community ambulation and poor quality of life. The main objective of this
study is to test both efficacy and neurophysiological mechanisms of a novel approach to treat persistent gait
deficits after stroke with a combination of simultaneous non-invasive brain stimulation with transcranial Direct
Current Stimulation (tDCS) and gait training. Rationale: Peripherally directed gait therapies are driven by
functional brain changes. tDCS has been shown to enhance functional brain changes during rehabilitation and
improve outcomes. Its ease of use and safety makes tDCS an ideal technology to pair with simultaneous gait
training methods. Upper limb studies showed that 10-session bihemispheric tDCS in combination with
movement therapy produced clinically meaningful improvement compared with minor changes after therapy
alone. We conducted pilot studies that demonstrated both feasibility and tolerability of the proposed
intervention. Our first single-session crossover pilot study demonstrated a potential benefit of tDCS combined
with gait training compared with gait therapy alone. Our second 10-session pilot study showed feasibility of the
intervention and demonstrated clinical improvements. The next important step is to test it in a randomized
control study. We will use a bihemispheric tDCS montage that can address a key adaptive neuroplastic
mechanism involved in post-stroke motor recovery, that is rebalancing interhemispheric interaction by 1)
facilitation of the residual ipsilesional motor output pathways for the lower extremity and 2) suppression of
transcallosal inhibition from the contralesional motor regions. Study Design: We will enroll 50 chronic stroke
subjects (>6 months) with gait deficits. Subjects will be randomized to 10 sessions of either active tDCS+gait
training or sham tDCS+gait training. Gait training will be accomplished in the treadmill-based Virtual Reality
environment targeting longer single limb stance with the paretic limb. Aim 1 is to determine whether the
combination of simultaneous tDCS and gait training produces greater improvement in gait performance
compared to gait training alone. The primary outcome measure will be both gait speed as measured by 10-
Meter Walk test (TMWT) and paretic single limb stance duration. Secondary outcome measures will assess
various components of gait-related functional domains and will include the following: spatiotemporal gait
asymmetry; another gait-speed-related measure (Timed Up and Go (TUG)); Ground Reaction Force; gait
kinematics; a measure of gait coordination (Gait Assessment and Intervention Tool); a measure of sensory-
motor impairment (Fugl-Meyer); a functional gait measure (Functional Gait Assessment); and dynamic balance
(miniBEST test). Aim 2 is to characterize the neuroplastic brain changes in response to bihemispheric tDCS
combined with gait training. Outcome measures are 1) ipsilateral corticospinal excitability (motor evoked
potential recruitment curve (MEP-rc)),2) asymmetry of interhemispheric excitability (bilateral MEP-rc ratio), 3)
functional connectivity between bilateral primary motor regions (resting state functional Magnetic Resonance
Imaging (rs-fMRI)). Aim 3 is to identify factors that predict gait improvement in response to tDCS with gait
training. We will evaluate the relationship between changes in gait speed and paretic single limb stance
duration and baseline assessment of structural and functional reserve (according to corticospinal tract lesion
load, clinical impairment, functional connectivity) and tDCS induced current density modeling. Significance:
This study will address an important problem for the VA patient population. We will test for the first time
whether bihemispheric tDCS can enhance gait training in chronic stroke and evaluate neuroplastic
mechanisms involved in this therapeutic approach. Combination of tDCS and efficient VR-based gait training is
a novel therapeutic approach that is being driven by promising preliminary data and supported by
multidisciplinary expertise.

Public health relevance
Stroke affects upwards of 800,000 Americans every year and has an enormous impact on the well-being of the American veteran population with 6,000 new stroke admissions every year. Many of these stroke survivors are living with walking disabilities. Gait problems result in inability to function independently, high risk of falls and poor quality of life. Unfortunately, current gait rehabilitation treatments are limited and many stroke survivors do not achieve full recovery. Therefore, it is critical to develop new approaches to enhance gait rehabilitation methods. We propose to evaluate a brain stimulation treatment called transcranial Direct Current Stimulation (tDCS) that can be added to physical therapy. tDCS has been applied for arm rehabilitation after stroke with positive results, but gait-related investigations are lacking. We will test whether simultaneous tDCS and gait training produces greater improvement in walking abilities than gait training alone. Adjunct tDCS therapy may improve outcomes, and reduce cost of both rehabilitation and post-stroke care. !